Domestication and characterization of TM7-the most elusive oral phylum

DESCRIPTION (provided by applicant): The human microbiome project has provided a comprehensive inventory of the microorganisms associated with the human body. The next challenge is to understand their role in human health and disease which requires cultivation of the species of interest. Relevant to this application, more than half of the oral microorganisms are categorized as uncultivated phylotypes including many associated with oral microbial pathogenesis. Among them, members of the candidate division TM7 phylum are the most enigmatic bacterial group in the oral cavity. Despite their ubiquitous occurrence in human body sites and other environments, no TM7 representative has been cultivated as pure culture. As a phylum containing suspected pathogens associated with inflammatory mucosal diseases, particularly periodontitis, cultivation of TM7 and the ability to investigate their pathogenic features has become like a Holy Grail in microbiology. Using a novel medium and enrichment techniques, we were able to reduce TM7-containing cultures from a complex community to dual-species co-cultures containing the disease associated TM7 phylotype (TM7x) together with Atopobium parvulum or Veillonella atypica as partner strain. We hypothesize that the growth of TM7x requires specific partner species and that understanding their relationship may be the key for isolating pure culture of TM7x. Furthermore, the present semi-pure cultures of TM7x and the possible pure TM7x cultures obtained through this study will enable our ability to study genomics, interactomics and the pathogenic potential of TM7x. This application aims to test our hypothesis and achieve these goals through detailed molecular analyses of the relationship between TM7x and its partner species, improving the medium for cultivating pure TM7x, as well as exploring its pathogenic potential. The immediate impact of the study is the discovery of cultivation conditions for TM7x and the associated biological/physiological functions. The long-term significance of the study is the creation of a new pathway for cultivation of many other yet-to-be cultured potentially pathogenic species.

Public health relevance
PUBLIC HEALTH RELEVANCE: Many of the harmful bacteria that live in our mouth cannot yet be grown in the laboratory and researchers can therefore not study how they cause disease. Our research is focused on finding new conditions to grow these bacteria in the test tube by studying their behavior when they grow in the presence of other bacteria that they need. Once we understand how to grow these bacteria in the laboratory, we can do experiments to investigate their role in our health and disease.